Senior Leadership

PROJECT SUMMARY (See instructions): The Director of the St. Jude Comprehensive Cancer Center (SJCCC), six Associate Directors, and the eleven Program Leaders provide critical leadership for all aspects of the SJCCC and, along with a select group of additional institutional leaders, comprise the internal Cancer Center Advisory Committee. Dr. James Downing, the Center's Associate Director for Basic Research, has the important oversight of the Center's Shared Resources. Dr. Victor Santana, the Associate Director for Clinical Research, has oversight responsibility for the clinical trials infrastructure. Due to specialized efforts requiring specific attention, there are also Associate Directors for Administration (overseeing fiscal and administrative aspects of the Center), Cancer Prevention and Control (coordinating the extensive epidemiologic and intervention research efforts of the SJCCC), Outreach (leading efforts in International Outreach and lay education for issues related to childhood cancers), and Education and Training (supporting the recruitment of postdoctoral fellows and organizing didactic training for graduate students and fellows). Each of these Associate Directors has an infrastructure of individuals who report to them and support their efforts to carry out these functions that are vital to the mission of the SJCCC. CCSG funds are requested to partially support the work of the SJCCC Director and Associate Directors for their roles in providing Senior Leadership to the Cancer Center: Richard Gilbertson, M.D. James Downing, M.D.: Raul Ribeiro, M.D: Leslie Robison, Ph.D: Victor Santana, M.D: Dana Wallace, M.S: Gerald Zambetti, Ph.D: Ph.D: Director SJCCC, CCSG Principal Investigator. Associate Director, Basic Research Associate Director, Outreach Associate Director, Cancer Prevention and Control Associate Director, Clinical Research Associate Director, Administration Associate Director, Education and Training

Public health relevance
RELEVANCE (See Instructions): The Senior Leadership team defines the overall vision and research priorities of the Center and provides high-level management of all its scientific, clinical, educational and outreach endeavors. The Senior Leadership also provides important fiscal oversight and management of Center activities and supports the Director in his role as primary leader ofthe SJCCC.